In vivo analysis of gastrointestinal epithelium morphogenesis

? DESCRIPTION (provided by applicant): The goal of this study is to investigate the cell biological mechanisms that drive the formation of the gastrointestinal epithelium. Although much progress has been made in understanding in the molecular genetics of gastrointestinal tract development and disease, the dynamic cell behaviors that contribute to organ shape and function are less well understood. During embryonic development, endodermal cells initially undergo a phase of highly dynamic single-cell migration but then later converge and adhere together into a coherent endodermal sheet, which ultimately gives rise to the epithelial lining of the gut tube. For this study, I will use high-resolution fluorescence imaging of live zebrafish embryos to investigate the transition from single- cell migration to epithelium formation. Preliminary experiments suggest that endodermal cells initiate epithelium formation by upregulating cell junction molecules to facilitate adhesion between cells while also spatially regulating actin polymerization and membrane protrusion to close gaps in the newly forming sheet. In the first aim of this study, I will determine the mechanisms by which cells identify cell free areas and extend their membrane across these gaps. Concurrently, I will define the progression of cell-cell adhesion by monitoring the dynamics of fluorescently labeled cell junction components alpha-catenin, E-cadherin, and ZO- 1. Finally, I will use RNA-Seq transcriptome profiling to identify new factors in endodermal sheet formation and will test the function of these new candidate genes by generating mutants with CRISPR/Cas9 technology. In Aim2, I will explore the role of the cytoskeletal gene septin9a (sept9a) in endodermal sheet formation. I had previously identified sept9a as gene that is upregulated specifically in the endoderm at the onset of sheet formation. Septins are known to regulate changes in cell shape and cortex tension, which may provide the necessary structural integrity to form a coherent epithelium. In this aim, I will characterize the effects of sept9a loss-of-function mutations on endodermal cell motility, cell-cell interactions, and the initiation and maintenance of cell-cell adhesion. Proper formation of the gastrointestinal epithelium is required for the tissue to perform its functions in barrier protection, digestion, and nutrient absorption, and defects in epithelial structure may lead to diseases such as inflammatory bowel disease. However, much of our current understanding of epithelium formation has come from in vitro cell culture systems that may not accurately represent epithelial differentiation as occurs in a developing embryo. Thus, the early zebrafish endoderm may be a much-needed in vivo model of de novo epithelium formation. This model could be used in future studies exploring fundamental aspects of epithelial biology as well as the cell biological mechanisms underlying gastrointestinal disorders and diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: The gastrointestinal epithelium performs many important functions such as digestion, nutrient absorption, and forming a barrier against gut microbes, and structural defects in this epithelium may lead to diseases such as inflammatory bowel disease. This study will advance our knowledge of how the gastrointestinal epithelium is formed, which will give us a better understanding of how tissue structure can contribute to the development of digestive disorders and diseases.